EMBRYOLOGY

DESCRIPTION (provided by applicant): For over 108 years, the Marine Biological Laboratory has offered the Embryology Course, which has played an important role in the training of American developmental biologists. The course trains pre-and post-doctoral students for research careers in developmental biology in a unique physical and intellectual environment, not duplicated elsewhere in the nation. The Embryology Course consists of a series of formal lectures, informal seminars, extended discussions, and intensive laboratory research experience delivered !r a six-week period in the summer. Course students are selected who are committed to teaching and research careers in the field of developmental Biology, and are chosen from an international applicant pool. Traditionally, a number of the students from each year's class later move into positions of leadership in the international Developmental Community. The teaching faculty are senior scientists in the field, some of them serve as instructors and lead research modules in the course, and others who give lectures and lead whom discussion on individual topics. The course consists of three modules, each of which is two weeks long. The module is staffed by an average of three-four resident instructors plus a comparable number of outside Lecturers. The themes of the modules change from year to year as important developments in the field Inge. The course introduces students to a large number of terrestrial and marine embryos including elegans, Drosophila, ascidians, sea urchins, amphibians, zebrafish, chick and mouse. Techniques include current molecular biological techniques, embryonic manipulation, microinjection and micromanipulation, microscopy and computer enhanced imaging technologies, and a number of immununochemical and in situ hybridization approaches. Students are challenged to formulate and test hypotheses in a well-equipped research environment and under the guidance of experienced research faculty and assistants. In support of the course, the Marine Biological Library provides a unique learning environment, laboratory and support facilities, an animal collection facility, and one of the nation's finest rearch libraries.